Buffalo Research Innovation in Genomic and Healthcare Technology (BRIGHT) Short-Term Training and Education

Biomedical Informatics is an inherently interdisciplinary field of study that requires
researchers to have a knowledge base in numerous domains, including: biology,
medicine, public health, ontology, human factors, and data science. This
multidisciplinary nature presents as a barrier to precocious students who may have an
interest in Biomedical Informatics but lack the prerequisite foundational skills and
knowledge. We aim to reduce that barrier to entry with our proposed research education
program by equipping undergraduate and master’s students with the skills to enable them
to begin their career via graduate education or workforce employment. At the same time,
we need a special focus on increasing excellence for our learners.
We propose a 12-week Buffalo Research Innovation in Genomic and Healthcare
Technology (BRIGHT) short-term training and education program at the University at
Buffalo’s Jacobs School of Medicine and Biomedical Sciences in the Department of
Biomedical Informatics. Every year this program will host 12 top undergraduate and
master’s candidates for intensive training in Biomedical Informatics and Data Science
involving didactics, hands-on research, and career development activities. Our overall
objective is to recruit and train the best undergraduate and masters’ students to prepare
them for future careers in Biomedical Informatics and Data Science.

Public health relevance
We propose a 12-week Buffalo Research Innovation in Genomic and Healthcare Technology (BRIGHT) short-term training and education program at the University at Buffalo’s Jacobs School of Medicine and Biomedical Sciences in the Department of Biomedical Informatics. Every year this program will host 12 top undergraduate and master’s candidates for intensive training in Biomedical Informatics and Data Science involving didactics, hands-on research, and career development activities. Our overall objective is to recruit and train outstanding undergraduate and masters’ students to prepare them for future careers in Biomedical Informatics and Data Science.